Community Liaison and Recruitment Core

Project Summary/Abstract
The primary objectives of the Deep South RCMAR Community Liaison and Recruitment Core (CLRC) are
to 1) educate, train, and mentor Scientists in community-engaged theory-based approaches to engaging older
Black/African Americans (B/AAs) in health-related intervention research, 2) assist RCMAR Scientists in
recruiting older AAs into their research studies, and 3) build a sustainable infrastructure that will generate and
disseminate new knowledge regarding the science of recruitment and retention. Our approach to recruitment
and retention draws upon research that addresses the role of culture in promoting health among older AAs.
There are cohort differences between younger and older AAs because of greater institutional policies of racism
and discrimination experienced by minority elders. Consequently, for health information, older AAs rely, to a
greater extent, on their minority segregated communities, their cultural values, and their kinship systems. In
addition to family and extended kinship networks, older AAs place high value on their religious beliefs and
practices. Because of this, recruitment and retention endeavors should reflect this rich cultural fabric and
employ community engagement strategies that are theory-based and culturally relevant.
In this application, we build upon our existing community-based infrastructure that has fostered community
capacity for active engagement in clinical research and has served as a catalyst to increase participation of
older AAs in health-related intervention research studies. Through the activities of the CLRC, we expect that
RCMAR Scientists will continue to have access to evidence-based recruitment and retention tools for both
urban and rural older AAs, and realize enhanced participation of older AAs, greater community “buy-in” to
research projects, and clearer routes of dissemination and intervention sustainability. Our CLRC has
successfully engaged rural and urban communities via broad-based efforts aimed directly at individuals, as
well as organizational conduits such as community-based groups and agents of change. We envision
continued mutually beneficial engagement fostering opportunities both for the CLRC and RCMAR Scientists to
solicit community input on the development of potential research questions and for community members to
enjoy enhanced access to state-of-the-art clinical research focused on older AAs.
To accomplish these broader goals, we propose the following specific aims for the Community Liaison and
Recruitment Core of the Deep South RCMAR:
1. Work collaboratively with the Research Education Component (REC) to educate, train, and mentor
RCMAR Scientists regarding the theory and approach to community engagement and assist
RCMAR Scientists in recruiting older AAs to their research studies
2. Advance scientific knowledge in recruitment and retention of older urban and rural AAs by
empirically testing recruitment and retention strategies developed in partnership with community
members
3. Expand capacity for community-academic partnerships by providing health education seminars
and grant-related education for community partners. Many community partners are interested in
securing small funds to support their community-related projects.
4. Disseminate research findings to the scientific community and the communities we serve.